How discrete homeostatic signals stabilize synapse function across time

PROJECT SUMMARY
Background and Objectives: Synapses and circuits possess a robust capacity for keeping their outputs stable.
Using the Drosophila melanogaster neuromuscular junction (NMJ) as a model synapse, many labs have recently
identified dozens of signaling molecules and processes that stabilize synapse function through a non-Hebbian
form of homeostatic neuroplasticity called presynaptic homeostatic potentiation (PHP). These findings offer a
rich reservoir for discovery science, but at this point we have little understanding of how dozens of discrete
homeostatic signaling molecules integrate into coherent system that stabilizes synapse function over time. The
objective of this proposal is to solve that problem combining genetics, pharmacology, imaging, biochemistry, and
electrophysiology. Ultimately, improved knowledge about homeostatic forms of synaptic plasticity could lead to
a better understanding of neurological disorders that occur when synapse stability is lost.
Specific Aims and Research Design: This project has two specific aims. We know that PHP at the Drosophila
NMJ can be acutely induced in minutes and then chronically maintained for days. The first aim is to define a
sequence of events that occurs during the opening minutes of PHP induction. For this aim, we take advantage
of a serendipitous finding from a genetic screen: impaired chaperone function in the muscle slows PHP signaling.
Using this genetic tool we will delineate an order of processes that occurs as the muscle signals to the nerve
and potentiates release. For the second aim, we developed a new pharmacological approach to monitor the
transition periods between induction, acute expression, and long-term maintenance of PHP. We will apply this
new method to characterize about 25 known genetic conditions that impact the sustained maintenance of PHP.
We expect to define distinct PHP signaling modalities. Between our aims, the expected outcome is a model of
how a synapse can sustain homeostatic function by integrating multiple signals across phases of time.
Health Relatedness: Neurological disorders like epilepsy, ataxia, and migraine are associated with unstable
neuronal function. Understanding how synapses work to maintain stability on a molecular level could have pro-
found implications for disorders with underlying neuronal instabilities. Yet the signaling events that tightly control
levels of synaptic output are poorly understood. The tractable Drosophila NMJ employs homoestatic strategies
to stabilize synapse function – such as altering levels of presynaptic calcium influx – that are shared by
mammalian central synapses. Taking advantage of the molecular and genetic tools offered by the NMJ promises
to shed light on universally conserved mechanisms of how synapses maintain stable function throughout life.

Public health relevance
PROJECT NARRATIVE Health Relevance Narrative: Instability of neuronal function can be debilitating, as evident from its association with numerous neurological disorders – including forms of epilepsy and migraine that present with acute attacks, or forms of neurodegeneration which can manifest in decades-long problems. In order to develop more effective treatments for disorders caused by unstable function, we need a better understanding of how neurons maintain stability. This proposal addresses that problem, using a genetic model system.